Vanderbilt University Medical Center (VUMC) CoFAR Clinical Research Center

PROJECT SUMMARY/ABSTRACT
This application is in response to RFA-AI-22-076 to establish a Clinical Research Center at Vanderbilt University
Medical Center for the Consortium of Food Allergy Research. The goal of this application is to establish the
infrastructure for a CRC that will then successfully, efficiently, and rigorously conduct both CoFAR-wide clinical
studies along with advancing the science and understanding of the food allergy syndrome related to alpha-gal.
These goals will be pursued via the following specific aims:
Specific Aim 1: Establish infrastructure for the VUMC CoFAR CRC, which is capable of rapidly implementing
and executing single site and multi-center clinical trials, with high quality and fidelity, focused on the prevention
and management of patients with food allergy, supplemented by studies to better elucidate the mechanisms
underlying food allergies and, in particular, alpha-gal syndrome. This CRC will serve as an opportunity for New
and Early-Stage Investigators to contribute to these projects and advance their independent research careers.
Specific Aim 2: Develop and conduct a consortium-wide, multi-center, non-inferiority clinical trial to evaluate the
comparative effectiveness of early peanut introduction with once weekly peanut feeding (low weekly peanut
protein dose, 2 gm) versus thrice weekly peanut feedings (standard weekly peanut protein dose, 6 gm) in the
prevention of peanut allergy in at risk infants.
Specific Aim 3: Based upon the concept that alpha-gal syndrome (AGS) is clinically manifest as a wide spectrum
of clinical presentations, we aim to better understand (1) why some patients in tick-endemic areas develop
clinically evident AGS after a bite, while others do not, and (2) why the clinical expression of AGS is variable
amongst patients and changes over time.

Public health relevance
PROJECT NARRATIVE Food allergy exerts substantial impact on affected individuals, their families, and society, including lifestyle limitations and reductions in quality of life. This application from the Vanderbilt University Medical Center (VUMC), will address the following goals: (1) establish the VUMC CoFAR CRC, which will rapidly implement and execute single site and multi-center clinical trials, with high quality and fidelity, focused on the prevention and management of patients with food allergy, supplemented by studies to better elucidate the mechanisms underlying food allergies; (2) develop and conduct a consortium-wide, multi-center, clinical trial to evaluate the comparative effectiveness of once weekly peanut feeding (low weekly peanut protein dose) versus thrice weekly peanut feedings (standard weekly peanut protein dose) in the prevention of peanut allergy in infants at high risk for the development of peanut allergy; and (3) to better understand the alpha-gal syndrome (AGS), specifically why some patients in tick-endemic areas develop clinically evident AGS after a bite, while others do not, and why the clinical expression of AGS is variable amongst patients and changes over time.